Editing the Neural Basis of Perception

Project Summary:
Neural computation requires the coordinated effort of thousands of interrelated and often genetically similar
neurons. These neurons form physically intermingled networks and subnetworks that act together to amplify
and strengthen sensory perceptions or select motor action. Such co-active ensembles are known to be
preferentially interconnected, and may represent a functional element of neural processing with unique
properties, such as pattern completion and competition between ensembles. In this proposal I will gain a
mechanistic understanding of how ensembles of co-active neurons interact by probing the function of
individual and groups of neurons in an awake mouse. I will examine: how ensembles of pyramidal cells
interact with other pyramidal cells and local inhibitory neurons in a visual task, how these ensembles influence
motor behavior, and how specific ensembles respond to information from other cortical areas. Despite the
potential importance of ensembles in cortical coding, the intermixed nature of these groups has made them
particularly hard to study. While conventional optogenetic techniques can manipulate genetically identified
neurons in a region, they are incapable of selectively manipulating intermingled neurons that differ only by their
functional properties. Critically, new multiphoton optogenetic techniques are beginning to allow manipulation of
cells chosen by their activity alone, however such techniques require further development. In the K99 phase of
this proposal, I will continue my training through the development of novel optical systems for multiphoton
stimulation and through use of these technique understand cortical function. By combining these new optical
techniques with novel opsins designed for in vivo multiphoton use that I have already developed, I now have
the ability to write in or edit neural activity across many neurons with a precision never before possible. By
altering ensemble activity during visual perception I will determine the causal contributions of individual
neurons as well as populations of neurons to sensory coding. In the R00 phase, through manipulations in
motor cortex I will unravel the behavioral impact of these groups, probing the role motor ensembles play in
motor action, and study how neurons interact across modalities. The ability to both edit and monitor the activity
of neural subnetworks is critical to gaining a mechanistic understanding of perception and action. The
conclusions we draw from this proposal will help to describe how all information is presented in the cortex, but
can only be reached with advanced techniques.

Public health relevance
Research Narrative. Brain function requires the coordinated action of hundreds or thousands of intermingled neurons. These neurons form groups to encode sensory perception and motor actions. We will use new technology to see how these groups of neurons influence each other during visually guided actions in a way that has never before been possible.